ROS-induced SPIO Targeted Platform for Transarterial Liver Cancer Therapy

Title: SPIO-GOx conjugate for transarterial liver cancer therapy
Abstract:
Hepatocellular carcinoma (HCC) is the sixth most common malignancy worldwide and ranks
third amongst cancer-related deaths, with over 700,000 new cases diagnosed each year.
Improved therapies for this disease is urgently needed. Cancer cells die in three ways:
apoptosis, necrosis and autophagy. A significant increase in intracellular reactive oxygen
species (ROS) can cause irreversible oxidative damage, leading to cell death through both
apoptosis and necrosis. Recently, our team created a novel SPIO-GOx nanoplatform,
synergizing ROS and metabolic depletion therapies. Using in vitro and in vivo studies, we found
this nanoplatform could produce very high levels of ROS and highly efficient tumor cell
destruction. Maximizing the therapeutic profile of this agent through targeted delivery and
minimal systemic toxicity will be crucial for effective clinical translation. Transarterial
chemoembolization (TACE), where chemotherapy is delivered directly into tumor-feeding
arteries, is the current standard of care for unresectable HCC. TACE synergizes delivery of
chemotherapy with embolization of tumor blood vessels while significantly minimizing toxicity
due to targeted delivery. In this project, we plan to leverage our innovative SPIO-GOx
theranostic nanoplatform with trans-arterial delivery technology to investigate the potential
application in liver cancer treatment. If successful, we may advance the science of liver cancer
treatment using this novel theranostic nanotherapy.

Public health relevance
Project Narrative: Despite effectiveness of transarterial chemoembolization (TACE) in Hepatocellular carcinoma (HCC), TACE remains non-curative with high recurrence rates. In this project, our recently developed glucose oxidase-based theranostic nanoplatform, synergizing reactive oxygen species (ROS) generation with tumor glucose depletion, will be combined with trans-arterial delivery technology to maximize targeted delivery to HCC with a significantly improved therapeutic profile, reducing systemic toxicity associated with traditional intravenous administration.